Administrative Core

CORE A- SUMMARY/ABSTRACT
Administrative Core (Core A) will be providing all the necessary administrative support and coordination to the
Project Leaders, Core leaders and other investigators and researchers involved in these studies in order to
successfully accomplish their scientific goals. Therefore, Core A will be critical for the overall success of this
Program Project. This success will be relying vitally on its supports in organizing the scientific and administrative
aspects of each Projects, and all the interactions amongst the all the members and with the Cores. Core A will
be responsible for managing the interaction amongst all members of the PPG as a whole and all the necessary
conferences and meeting amongst the Project and Core Leaders to facilitate data generation, integration and,
importantly maintaining very high level of synergy amongst the projects. It will provide critical logistical support
for highly important tasks such as grant renewals, budgetary issues, adherence to rules and regulations of
institutions and National Institute of Health (NIH) and submission of abstracts and manuscripts. Finally, Core A
will manage all the IACUC related issues surrounding animal welfare and care as well as the financial
management activities. Core A will oversee the efficient utilization of the allocated funds, while conforming to the
regulations of the associated institutions and NIH. The duties of Core A will be performed by the Program
Manager/Administrative Assistant (Naima Banouni), under the direction of Dr. Abdi, and by the Financial
Manager/Grants Financial Specialist (Ms. Andrea Depatie). Ms. Banouni will be responsible for arranging the
meetings between PIs of Projects and Cores, the members of internal and external advisory board, and the
investigators. She will also assist with the submission of abstracts, manuscripts, presentations, and progress
reports, as well as maintain the lines of communication between the groups interacting in the Program. Ms.
Depatie will oversee the financial management including budget handling, accounting and monitoring of
expenditures, as well as preparation of yearly annual budgets and all necessary budget related documents
required for renewals.